Methods for Selective Organic Synthesis based on Ionic Catalysts

Project Summary
The major goal of this research program is to develop catalytic enantioselective
transformations based on transition metal and chiral anion catalysis that will be broadly
applicable to the preparation of therapeutically relevant organic molecules. Towards this
end, new reactions for the enantioselective construction of C-O, C-N and C-halogen
bonds are proposed. Particular emphasis is placed on the development of methods for
the selective introduction of fluorine and fluorine-containing functional groups.
Additionally, reactions that generate or employ available building blocks, such as
alkenes and boronic acids, will be targeted. These methods will leverage new catalyst
platforms, based on gold(III) complexes and phosphoric acid-based chiral anions, for the
construction of fluorinated building blocks and heterocycles Additionally, the
mechanistic underpinnings of these reactions will be studied, with a focus on
uncovering the role of non-covalent interactions in achieving selectivity. Thus, we
anticipate that this program will provide synthetic chemists and biomedical researchers
with additional tools (reactions, catalysts, ligands etc.) for molecular synthesis and for
single enantiomer construction, as well as provide principles for further development
and application.

Public health relevance
Narrative The proposed program aims to develop new methods for the preparation of structures and compounds of potential importance to medicinal chemistry. Transition metal-catalyzed, organocatalytic and dual catalytic processes that target the formation of carbon-heteroatom, including carbon-fluorine bonds, are proposed. Studies unravelling the mechanistic underpinnings of these reactions, including those leveraging modern data science, will be undertaken.